The Role of Biofilm on Margin Stability and the Development of Secondary Caries

DESCRIPTION (provided by applicant): More than 70% of carious lesions (now over 125 million per year) are restored with acrylate-based resin composites which have a median service-life of less than 6 years (vs. 15 years for amalgam). The major reason for replacing these restorations is because of secondary caries, but the reason these lesion develop more rapidly on resin-based composites is unclear. Previous clinical studies on the relationship of the margin gap to the development of secondary caries have resulted in equivocal results due to the complexity of interacting variable and the inability to accurately monitor gap dimensions. More controlled in vitro experiments have focused on amalgams and not resin-based composites. This research will investigate a commercial acrylate-based resin dental composite and relevant polymer systems with the following specific aims: (1) to determine the role of the microgap in the development of secondary caries in human teeth, (2) to define how gap dimension controls the occluded chemistry within the gap, and (3) to determine how the occluded chemistry impacts the structure and properties of the resin and composite. This will be accomplished in a 4 year research effort with a multidisciplinary team and newly available measurement tools and techniques. Restorations with naturally formed microgaps and model restorations with precisely controlled microgap dimensions will be exposed to a realistic, controlled in vitro environment consisting of a consortium of oral bacteria relevant to caries in artificial saliva. The effects of the microbial biofilm on the tooth and the composite surface near the cavosurface margin and on the microgap dimensions will be monitored non-destructively with submicron resolution with a new interferometric technique, Super Resolution Vertical Scanning Interferometry. The relationship of gap dimensions, the activity of the different bacterial strains, and frequency and severity of secondary caries will be determined. In addition, the pH and Ca2+ concentration within the microgap will be measured as a function of depth and time with micro-sensor techniques that are new to dental research. Finally, the direct effect of the occluded microgap chemistry on the resin composite properties and chemistry will be examined using dynamic mechanical testing, fatigue measurements, and a newly developed minibeam technique, as well as FTIR to determine if there is direct evidence of backbone scission by hydrolysis. The successful completion of this research will conclusively test a leading theory for secondary caries in resin-based composites, critically examine the efficacy of these materials for use in dentistry, and develop new, more precise tools for biomaterial investigations in the laboratory and the clinic.

Public health relevance
PUBLIC HEALTH RELEVANCE: Resin-based dental composites are the principle material used to restore over 120 million cavities each year in the US, but have a very limited service-life that is 40% of an amalgam. This program will use newly available tools and experimental methods to critically evaluate the efficacy of these materials for use in dentistry. New, more precise methods will be developed for biomaterial investigations in the laboratory and the clinic. PROJECT NARRATIVE Resin-based dental composites are the principle material used to restore over 120 million cavities each year in the US, but have a very limited service-life that is 40% of an amalgam. This program will use newly available tools and experimental methods to critically evaluate the efficacy of these materials for use in dentistry. New, more precise methods will be developed for biomaterial investigations in the laboratory and the clinic. __SpecificAimsTextDelimiter__ 1.0 SPECIFIC AIMS Dental caries is the single most common chronic disease amongst adults, adolescents, and children in the United States. More than 70% of carious lesions, now representing over 125 million per year, are restored with acrylate-based resin composites. However, in spite of their extensive use, dental composites have a median service-life of less than half of an amalgam (6 vs. 15 years respectively). The principal reason attributed to dental restoration failure is secondary caries, which are believed to originate through microleakage via gaps between the cavosurface wall and the restoration. Gaps form from the inherent shrinkage that accompanies acrylate polymerization, but it is unclear whether these gaps actually lead to the formation of secondary caries. In vivo clinical investigations into the origin of secondary caries and their association with gap size have been inconclusive. The reasons for this include: the use of imprecise measurement tools in the clinic, variability in saliva chemistry and microbial flora, and variability in the mechanical contribution to degradation between individuals and its synergy with chemical degradation. The correlation inconsistencies may also be related to the interdependence between the gap dimensions, the occluded chemistry that forms in the gap as a result of this dimension, and the inherent variability in microgap shape that forms in vivo. The acrylate used in essentially all resin-based dental composites contains hydrolyzable linkages in the backbone (e.g., esters), but there is currently no direct evidence of chain scission in the resin due to the microgap chemistry. The composition and kinetics of the microgap chemistry, and its impact on resin hydrolysis and composite mechanical properties are not known. Dentistry must determine how secondary caries develop in acrylate-based resin composites and how the occluded chemistry within the microgap affects the resin chemistry and resulting mechanical properties. Controlled methods and precise measurement are necessary to make these determinations. Recent technical advances available to our Houston Biomaterials Research Center now make these investigations possible. Therefore, the specific aims of this research are: 1. To determine the role of the microgap in the development of secondary caries in human teeth. This will be accomplished with a controlled in vitro environment using consortia of relevant oral bacteria in artificial saliva and two micro-gap models: naturally formed microgaps and controlled microgaps. The effects of the microbial biofilm on the tooth and the composite surface near the cavosurface margin and on the microgap dimensions will be monitored non-destructively with submicron resolution with a newly developed interferometric technique. The activity of the different bacterial strains will monitored over time using fluorescent techniques. 2. To define how gap dimension controls the occluded chemistry within the gap. For the first time, the pH and Ca++ concentration will be monitored over time and at different depths in the microgaps by using frozen sections and ion selective microelectrodes. 3. To determine how the occluded chemistry impacts the structure and properties of the resin and composite. For the first time, acrylate resin exposed to the occluded chemistry within the microgap will be assessed for direct evidence of chain scission. The flexural fatigue and viscoelastic properties will be characterized by using dynamic mechanical analysis. The successful completion of this research will conclusively test a leading theory for secondary caries in resin-based composites, critically examine the efficacy of these materials for use in dentistry, and develop new, more precise tools for biomaterial investigations in the laboratory and the clinic.